Interdisciplinary HIV Prevention Training Program

This Renewal Application for T32 seeks to continue a highly successful Pre- and Post-Doctoral Fellowship Training Program (established in 1999) in HIV prevention research at Yale University’s Center for Interdisciplinary Research on AIDS. Over the past 24 years we have successfully trained Post-Doctoral and Pre-Doctoral Fellows on HIV-related content knowledge, research skills, and professional growth and networking, and they have demonstrated tremendous productivity. The Yale AIDS Prevention Training Program is housed at the Center for Interdisciplinary Research on AIDS and within the Yale School of Public Health at Yale University. The integration with CIRA and Yale provides an exceptional training environment that continues to keep step with the changing HIV/AIDS pandemic. Our training program is unique in providing the following combination of perspectives: a focus on the latest in HIV prevention content knowledge including the four pillars of the Ending the Epidemic initiative (diagnose, treat, prevent, respond), mechanisms across the ecological model related to HIV prevention-treatment cascade (e.g., social determinants, neighborhoods) that have been linked to increased burden for HIV. Yale AIDS Prevention Training Program provides a strong foundation of training that emphasizes methodological skills and rigor in both quantitative and qualitatative analyses; opportunities to conduct ethically sound, community based research; the latest in digital health research; and implementation science skills and methods to support the design and evaluation of interventions that are tailored to local contexts and study populations. We are requesting support for 4 Pre-Doctoral and 5 Post-Doctoral slots per year. The focus of both the Pre- and Post-Doctoral Fellowship is “hands on” conduct of research, analysis, paper and grant writing using a tiered mentoring approach. All of our fellows are required to participate in a weekly seminar series. In additon, the Pre-Doctoral training also includes: formal course work, research preceptorship, seminars, outside courses and meetings, qualifying examinations, and dissertation research. Our approach to training future scientists for careers in HIV prevention research will emphasize flexibility and individual tailoring of Fellows’ research preceptorships, while recognizing the importance of core training in HIV content, research skills, and professional networking. Over the past 24 years we have successfully trained, and continue to train, 95 Fellows from a variety of disciplines. Fellows are both exposed to, and actively collaborate in, a wide array of studies and career trajectories, with an unprecedented opportunity to publish their own research. We are, therefore, confident in our ability to prepare both Pre- and Post-Doctoral Fellows with the strongest foundation of knowledge, skills, and experience to achieve and sustain careers as scientific investigators, contributing to advances in HIV prevention.

Public health relevance
Nearly 5000 new HIV infection occur per day, with the epidemic negatively impacting the most vulnerable populations resulting in health disparities. There remains a critical need to train investigators who are prepared to conduct primary and secondary prevention research in HIV. Our proposed Training Program will continue to provide the strongest foundation of knowledge, skills, professional networking and experience to young investigators at the pre- and post-doctoral levels, who can establish and sustain careers as scientific investigators, contributing to advances in HIV prevention.